Prognostic modeling of pediatric tracheostomy-associated respiratory tract infections

PROJECT SUMMARY:
Each year over 4,000 children undergo tracheotomy and account for more than 20,000 hospitalizations
annually most commonly due to acute tracheostomy-associated respiratory infections (TARI). These
hospitalizations are most often due to Pseudomonas aeruginosa infection. Efforts to improve the care of
children with tracheostomy are challenged by the limited body of evidence on how patient factors, features of
P. aeruginosa itself, and the child's immune response impact the risk of recurrent infection. This proposal will
address this critical knowledge gap by identifying and characterizing prognostic factors for frequent
rehospitalization in children hospitalized for TARI. In this K23 Mentored Career Development Award, Dr. John
Morrison will: 1) leverage existing data from a six-center prospective cohort study of children hospitalized for
TARI to identify clinical factors associated with recurrent TARI hospitalization; 2) prospectively determine the
association of pathogen-specific factors and features of the host immune response with frequency of recurrent
TARI hospitalization, and 3) derive a novel prognostic model incorporating clinical and molecular factors to
identify patients at increased risk for recurrent TARI hospitalization. Achieving these aims will facilitate Dr.
Morrison's long-term goal of leading prognostically-stratified interventional studies aimed at improving
outcomes for children with tracheostomy and others affected by frequent respiratory infections.
The applicant has dedicated his career to improving the care for children with chronic respiratory failure and
other medical complexity as a physician-scientist. He is an Assistant Professor of Pediatrics with the Johns
Hopkins University (JHU) School of Medicine at Johns Hopkins All Children's Hospital (JHACH) who seeks a
mentored career development award during which he will develop the advanced training, education, and
experience to become an independently funded investigator in biomarker-informed prognostic models and risk-
stratified clinical trials in children with tracheostomy. This proposal will provide Dr. Morrison with the support
needed to advance his career by 1) acquiring knowledge on the development and application of prognostic
modeling, 2) developing expertise in conducting biospecimen-based translational research, 3) preparing to
conduct a prospective, multicenter study validating a prognostic model and examining therapeutic strategies,
and 4) expanding his practical understanding of individual- and system-level factors contributing to recurrent
admissions among children with tracheostomy. Dr. Morrison will be supported by the extensive resources of
the Institutes for Clinical and Translational Research at JHACH and JHU and has assembled a strong team of
mentors with expertise in biomarker discovery, biomarker-informed prognostic modeling, and risk-stratified
clinical trials. He will also pursue coursework through the JHU Bloomberg School of Public Health in
biostatistics, molecular epidemiology, and clinical trial conduct to complement his experience in the basic and
clinical sciences and acquire the skills necessary to transition to independence.

Public health relevance
PROJECT NARRATIVE: Little is known regarding why children with tracheostomy experience recurrent respiratory infections despite receiving clinically appropriate antibiotic therapy. This proposal seeks to derive a novel prognostic model that incorporates clinical factors and mechanistically-based laboratory measures of pathogen antibiotic resistance and host immune response to identify children at greatest risk for recurrent tracheostomy-associated respiratory infections (TARIs). The findings of this work under a career development award will provide the basis for future risk-stratified interventional trials employing targeted therapies to reduce the frequency of TARI hospitalization among children with tracheostomy.